VISION: Volumetric Imaging for Science Instruction of an Open Nature

DESCRIPTION (provided by applicant): The goal of this Phase II Small Business Technology Transfer (STTR) application-entitled Volumetric Imaging for Science Instruction of an Open Nature (VISION)-is to adapt an advanced technology employed in biomedical research and practice-volumetric image processing and analysis (VIPA)-for science and mathematics education in formal secondary school settings. VIPA is used in biomedicine to display, model, and analyze volumetric data-typically imaging data that has been created by making two-dimensional digital "slices" of an object of interest-such as in magnetic resonance imaging (MRI), functional MRI (fMRI), computed tomography (CT), and single photon emission computed tomography (SPECT). VIPA is also employed in non-biomedical disciplines where volumetric analyses are of interest, for instance, Earth science, engineering, hydrology, oceanography, and oil and gas exploration. This project will create a multimedia application (VISION Software) containing five modules designed to supplement high school biology, Advanced Placement (AP) anatomy and physiology, and AP Biology instruction. The modules will be developed in an inquiry learning (IL) format in which students play the role of imaging scientists. Students will explore fascinating 3-D images;expand spatial thinking abilities by navigating 3-D data visualizations and changing the way the data is represented;master new quantification and technology skills by selecting and measuring features in microscopic and macroscopic specimens;enhance science process skills by working through all stages of a virtual research project;and learn standards-based science content. The materials will be developed by Science Approach, LLC, in collaboration with the Biomedical Imaging Resource at the Mayo Clinic, the New Media Research Institute, ten experienced teachers, five researchers, a commercialization advisor from the Carolina Biological Supply Company, and the West Texas Office of Evaluation and Research. The VISION modules will be released as a multimedia Shockwave file distributed on disc, via the Internet, or incorporated into other publications. PUBLIC HEALTH RELEVANCE: The proposed VISION project will provide opportunities for high school faculty and students to explore volumetric imaging data in a manner that currently not available in most high school classrooms. Not only will the proposed instructional materials highlight the key role that NIH-supported research plays in improving biomedical diagnoses, treatments, and research, VISION will promote development of a scientifically literate public that can carry forward the endowment of science and technology that has made the United States a leader in the field of biomedicine and provided its citizens with the high standard of living the nation enjoys.

Public health relevance
The proposed VISION project will provide opportunities for high school faculty and students to explore volumetric imaging data in a manner that currently not available in most high school classrooms. Not only will the proposed instructional materials highlight the key role that NIH-supported research plays in improving biomedical diagnoses, treatments, and research, VISION will promote development of a scientifically literate public that can carry forward the endowment of science and technology that has made the United States a leader in the field of biomedicine and provided its citizens with the high standard of living the nation enjoys.